Noninvasive modulation of deep brain circuits for treatment-resistant depression

Current interventions for depression lack the capability to directly, precisely, and noninvasively engage the
deep brain circuits at the core of the illness. We have developed a non-significant-risk, MRI-compatible,
individually-targeted, ultrasonic neuromodulation device that can stimulate deep circuits in humans
noninvasively with a precision previously achievable only with surgically implanted electrodes. This R61/R33
project will evaluate the potential for this novel device to engage deep brain targets and modulate mood
symptoms in individuals with treatment-resistant depression. The R61 phase will demonstrate target
engagement by delivering low-intensity ultrasound to the subcallosal cingulate during functional magnetic
resonance imaging. This phase aims to evaluate the intensity dependence, target specificity, and tolerability
of this neuromodulation intervention. If predefined go/no-go criteria are met, the R33 phase will then evaluate
the short-term effects of subcallosal cingulate neuromodulation using a randomized sham-controlled study
design. The aims of this phase are to examine the associations between target engagement, short-term mood
changes, and immediate changes in brain functional connectivity. The R33 also aims to evaluate tolerability
and feasibility of a subsequent efficacy trial. This project will address an unmet need by providing new,
noninvasive, circuit-directed treatment options for patients with treatment-resistant depression. Because this
ultrasonic neuromodulation device offers access to deep brain structures with a unique combination of
flexibility, precision, and noninvasiveness, the proposed work is expected to have broader positive impacts for
understanding and treating other disorders of deep brain circuits.

Public health relevance
Depression is a highly prevalent and debilitating brain illness that is often resistant to treatment. This project will evaluate a novel intervention that delivers low-intensity ultrasound precisely to the deep brain areas that cause depression. This work is expected to provide new noninvasive, individualized, flexible treatment options for an illness that weighs heavily on public health.